Quantitative proteomic analysis of the aging brain after intracerebral hemorrhage

Intracerebral hemorrhage (ICH) is a devastating subtype of stroke with no effective treatment. Lack of
treatment options partly contributes to the poorly defined pathophysiology of ICH. Along these lines, despite
the increasing prevalence of ICH in the elderly, the molecular level changes that occur in the aging brain after
ICH remains largely enigmatic. To address this critical knowledge gap, two specific aims are proposed. Aim 1:
To determine the age-induced changes in the brain proteome after ICH. Aim 2: To determine the age-induced
protein level changes in microglia and brain-infiltrating monocyte-derived macrophages (BMDM) after ICH. The
proposed studies employ a preclinical model of ICH and include unbiased and rigorous proteomics approaches
such as label-free and TMT-labeling Mass spectrometry and bioinformatics approaches. Successful completion
of the project would identify novel molecular regulators to improve the neurological outcomes after ICH in the
elderly. Also, the studies would define, for the first time, the proteomic profile of acutely isolated microglia and
macrophages, the cells that play key roles in brain damage and repair after ICH.

Public health relevance
Intracerebral hemorrhage (ICH) is a major public health problem with no effective treatment. Given the enormous potential of the proteomics approach, the successful completion of this grant will identify clinically relevant molecular targets for therapeutic intervention.